TXT Me: Texting Motivational Messages Encouraging Adolescent PA

DESCRIPTION (provided by applicant):This application proposes to develop an innovative intervention that promotes physical activity to 14-17 year olds and assess its feasibility. The intervention is guided by Self Determination Theory and seeks to enhance adolescents' feelings of autonomy, competence, and relatedness, and ultimately, internally-driven motivation to be physically active, thereby increasing the likelihood of sustainable increases in physical activity. Increasing physical activity in a manner that will be sustained will ultimately decrease risk of both obesity and certain cancers. PUBLIC HEALTH RELEVANCE: This application will test the feasibility of promoting PA to 14-17 year olds using text messages tailored to constructs from Self Determination Theory. Promoting PA to adolescents in a manner that is familiar, convenient, and acceptable has the potential to increase PA, thus reducing risk of both obesity and chronic disease, such as certain cancers.

Public health relevance
PROJECT NARRATIVE / PUBLIC HEALTH RELEVANCE This application will test the feasibility of promoting PA to 14-17 year olds using text messages tailored to constructs from Self Determination Theory. Promoting PA to adolescents in a manner that is familiar, convenient, and acceptable has the potential to increase PA, thus reducing risk of both obesity and chronic disease, such as certain cancers.